ESTIMATING SHUNT RESISTANCES OF GASTRIC EPITHELIUM OF MUDPUPPY

ONE OF THE AIMS OF OUR LAB IS TO MAKE AN EQUIVALENT CIRCUIT MODEL OF THE MUDPUPPY, NECTURUS MACULUOSUS, GASTRIC EPITHELUM. MUCH OF OUR PRIOR WORK ON THE EQUIVALENT CIRCUIT HAS ALREADY BEEN COMPLETED (DEMAREST AND MACHEN, 1985). WE HAVE YET TO DETERMINE THE MAGNITUDE OF THE PARACELLULAR SHUNT. THE MUDPUPPY HAS SEVERAL ADVANTAGES FOR DOING ELECTROPHYSIOLOGICAL STUDIES, MAKING IT MUCH EASIER TO USE THAN THE STANDARD MAMMALIAN MODELS. THESE INCLUDE LARGE CELLS AND A GASTRIC MUCOSA THAT READILY LENDS ITSELF FOR USE IN A TRANSEPITHELIAL VOLTAGE CLAMP. THIS PROJECT IS CURRENTLY IN PROGRESS. THE ACID-SECRETING REGION OF THE STOMACH OF VERTEBRATES IS A COMPLEX EPITHELIUM, SINCE IT IS COMPOSED OF SURFACE EPITHELIAL CELLS AND GASTRIC GLANDS. IN THE GASTRIC GLANDS ARE CHIEF CELLS AND PARIETAL CELLS IN MAMMALS AND OXYNTIC CELLS IN OTHER VERTEBRATES. BECAUSE OF THE PRESENCE OF MULTIPLE CELL TYPES, THE STANDARD MACROSCOPIC TRANSEPITHELIAL VOLTAGE CLAMP TECHNIQUES CAN NOT BE USED TO DETERMINE THE SHUNT RESISTANCES OF THE DIFFERENT CELL TYPES. THE VIBRATING PROBE, HOWEVER, CAN BE SITUATED ABOVE OPENINGS OF THE GASTRIC GLANDS AND ABOVE THE SURFACE EPITHELIUM IN THE REGION OF EACH OF THESE CELL TYPES. USING PHARMACOLOGICAL TOOLS, THAT INCLUDE AMILORIDE, CIMETIDINE, AND ION REPLACEMENTS, WE ARE ABLE TO DISSECT THE CURRENTS AND RESISTANCES DUE TO THE PARACELLULAR AND TRANSCELLULAR PATHWAYS.